CCR-Frederick Flow Cytometry Core

The CCR-Flow Core is an indispensable resource for NCI and contractor investigators at the Frdereick National Lab for Cancer research. Seventy investigators from 35 different laboratories have used the expertise of the flow core staff and the instrumentation available and maintained by the staff. The projects investigators have been studying include tolerization of the high-avidity T cells in the tumor microenvironment. Another study was of the critical role of tumor necrosis factor in stabilizing the CD4+Foxp3+ regulatory T cell. Regulation of the NF-B signaling pathway of pancreatic cancer stem cells was also studied. A project looking at the pivotal role of IKKalpha in spontaneous lung squamous carcinomas was also done. The influence of HLA-C expression on HIV control was also a project of study. Studies have been done on the role of DC cells in the acute infectious inflammatory process. The flow core staff has trained eighteen investigators in the first three quarters of the year to run their own samples. The instruments are used daily by the trained investigators often into the night and on the weekends. This leaves more time for the flow core staff to sort approximately 450 samples and analyze about 10419 samples in the first three quarters of this year. Without the investigators acquiring the data and analyzing their own samples, the government would have to hire full time experienced individuals to perform the same volume of work. At least 15 papers have been published, 8 papers are in press and 14 papers have been submitted in the past year using data obtained in the flow core. The future goals include keeping up with cutting-edge technology in the flow lab by expanding the pool of investigators trained to run and analyze their own samples to all of CCR in Frederick thereby expanding the use, productivity and quality of the science generated using the core's instrumentation and expertise. It is necessary to up-grade all of the instruments so that laser and fluorochrome capabilities are more interchangeable so that investigators have the flexability to use more than one instrument. This would prevent loss of data because the instrument needed was in use by another investigator or down because of needed repairs. It is critical to have this flexability in analysis of samples as well as for sorting of cells. We would also like to stay a cutting edge facility which would require at least one analyzer to be up-graded to analyze at least 28 parameters at once.